OTHER FUNCTIONS: SBIR PHASE 2 N44DA-12-4412 TOPIC 126 HIGH-PRECISION WEB BASED C

Under this Small Business Innovative Research (SBIR) Phase II project, the Contractor shall create software that enables substance abuse researchers and other psychologists to administer neuropsychological tests over the web with the same timing precision as traditional computer-administered measures.